Manufacturing Process Intensification for Pluripotent Stem Cell-Derived Rare Red Cell Production

Project Summary/Abstract
The goal of this Phase I STTR proposal is to manufacture designer red blood cells (RBCs) from a renewable
source of pluripotent stem cells in an economically intensified and scalable platform for distribution to relevant
US laboratories to be used as reagents in the identification of antibodies for patients requiring blood transfusion.
A common complication of chronic RBC transfusion therapy is alloimmunization, or the formation of
alloantibodies in response to antigens (proteins) present on the surface of donor RBCs that the recipient lacks.
Patients with sickle cell disease (SCD) are particularly at risk due to genetic variants in the Rh blood group
system. Alloimmunization has severe clinical consequences including high morbidity, delays in identifying
compatible blood, and delayed hemolytic transfusion reactions (DHTR) with worsened anemia. Identification of
the precise antibody target is critical for selection of donor units, transfusion effectiveness, and safety. The Chou
Laboratory (CHOP) combined human induced pluripotent stem cell (iPSC) and gene-editing technologies to
create a renewable source of cells with unique Rh profiles that facilitate the identification of complex Rh
antibodies. Donor-derived RBCs with these rare antigen profiles are currently available to only a few laboratories
and in very limited quantities. CHOP demonstrated that the RBCs derived from iPSCs (iRBCs) are compatible
with standard laboratory assays and can help determine the precise Rh antibodies in patient plasma. Safi
Biotherapeutics Inc (Safi) is a pre-clinical blood cell therapy company that has developed a cost-efficient and
scalable bioprocess for manufacture of human RBCs from hematopoietic stem cells. Safi’s manufacturing
expertise in stem cell-derived blood manufacture will be leveraged to design and demonstrate a process for bulk
manufacture, downstream process/formulation, and distribution of the iRBCs. This work will be accomplished in
two aims. The first will optimize RBC production from human iPSCs using economically intensified and scalable
technologies, and the second will validate the performance of the different product formulations in routine
antibody identification assays using patient samples. This work will define the process necessary to generate
sufficient quantities of iRBCs with specific Rh profiles and support the development of a phase II proposal to
scale up manufacture in preparation for commercialization of in vitro grown RBC reagents.

Public health relevance
Project Narrative The overall theme of this proposal is to develop an in vitro red blood cell manufacturing process that can produce sufficient quantities of customized red blood cells to be used in diagnostic assays for individuals requiring transfusion. These red blood cell reagents are needed to identify antibodies to antigens on donor cells, which is critical for selection of compatible donor units, transfusion effectiveness, and safety. The innovative solution presented here will address the challenges that occur from an insufficient supply of these specialized red blood cells on an international scale, with the ultimate goal of improving transfusion outcomes.